Defining the role of microenvironmental ammonia in colorectal cancers

Abstract:
Colorectal cancer is a grave public health concern with only a 14% survival rate for Stage IV diagnosis, and
few viable treatment options. Colon tumors are composed of a cadre of cells and the interplay between these
cells is critical for tumor growth. Previous work shows that the initial immune-tumor dynamic is robustly anti-
tumor, but that this anti-tumor response is attenuated as tumors progress. Immunotherapies that re-activate
the anti-tumor response are currently widely used in many cancers. Although colon tumors have a robust
immune infiltrate, immunotherapies have largely failed for unclear reasons. Further, cancer cells are known to
reprogram cellular metabolism to meet their proliferative needs. Cancer cell proliferation produces metabolic
waste products that can be re-purposed to maintain cellular bioenergetic needs. However, it is clear that the
vast majority of the metabolic byproducts accumulate in the tumor microenvironment. There is a critical gap
regarding how metabolic waste products interact with the immune infiltrates. My preliminary data demonstrates
that KRAS mutant colon tumors have an increase in ammonia waste that accumulates in the tumor
microenvironment. Moreover, my preliminary data shows that T cell proliferation and anti-tumor response is
significantly inhibited at biologically relevant concentrations that have been detected in colon tumors, while
other cell types are largely unaffected. I have also shown that chemical ammonia detoxification reduces tumor
growth in a T cell dependent manner. This suggests that ammonia waste contributes to the attenuated anti-
tumor immune response commonly observed in colon cancer. data I hypothesize that increased
microenvironmental ammonia in advanced cancers is central to maintaining an immunosuppressive
state by altering T cell function. The long-term goal of this proposal is to understand how colorectal tumors
modulate the microenvironment through metabolic products to decrease the effectiveness of the immune
response. Understanding this will advance the development of immune-based therapeutic regimens. Based on
these observations, the experimental focus of this proposal is on the regulatory role of tumor-generated
ammonia on T cell function. Aim 1 will determine whether KRAS mutation is driving ammonia accumulation in
advanced cancers. Aim 2 will explore how detoxifying ammonia in the tumor microenvironment increases the
T cell immune response, using both genetic and chemical interventions. Preventing this negative hetero-
cellular cross talk between the tumor and T cells may improve the efficacy of immunotherapy approaches in
colorectal cancer. Importantly, pursuing the aims specified in this proposal will provide rigorous scientific and
clinical training at a highly ranked and well supported institution. This type of institutional, facility, and mentor
support will further my path towards a career as a physician scientist with an active oncology laboratory.

Public health relevance
Project Narrative Metabolic interactions between colon cancer cells and immune cells in a tumor are essential for cancer growth and progression. I will use new mouse models and cutting-edge metabolomic and proteomic approaches to determine how metabolic waste products alter immune cells to support cancer growth.